Trans-NIH Angiogenesis Core Facility

Within the first two years of its existence (established May 2006) the Angio Core has accomplished all of the above site goals and is now expanding their efforts on these individual goals. In particular, organizing and putting together a techniques manual on all of the angiogenesis/lymphangiogenesis assay techniques they have developed, extending their intramural/extramural interactions, developing new CRADAs evaluating potentially new anti-angiogenic/anti-lymphangiogenic drugs, identifying novel neuropeptides that induce neovascularization that are possible candidates for intervention therapy and developing a dual transgenic mouse with targeted expression of CFP blood endothelial cells and RFP lymphatic endothetial cells allowing for simultaneous in vivo quantitation of angiogenesis and lymphangiogenesis in the same animal.